Chemical Development of Fluorescent Labeling Tags for DNA Damaged Sites

DESCRIPTION (provided by applicant): Numerous studies have shown a strong correlation between accumulations of DNA adducts during aging and carcinogenesis. However, these correlations have not generally resulted in monitoring of DNA adducts as biomarkers for monitoring susceptibility to human diseases, in part, because of the complexities of biochemical assays for the detection of lesions in DNA. Herein, we propose to develop new chemical reagents based on well established methodologies that should greatly simplify detection of many DNA adducts in purified DNA, tissue culture cells and clinical samples. The strategy is to synthesize fluorescent dye derivatives that will react with DNA backbone following excision of DNA adducts using lesion-specific DNA glycosylases. We will demonstrate the feasibility of this approach by using synthetic, followed by biochemical approaches for detecting uracils and 8- oxoguanines in purified DNA and mammalian cells. The dyes to be developed will be considered for membrane permeability allowing the application of this technology to determining uracil content of B cell lymphoma DNA in situ. The long term goal of this project is to develop new chemical and biochemical tools to improve upon existing methodologies, to quantify and localize, at chromosome level, consequences of human exposure to DNA-damaging agents.

Public health relevance
Project Narrative Cancer is disease created by damage to DNA that results in alterations such as mutations in the cellular genetic information. We propose here within, the development of sensitive and specific chemical tools as well as a novel biochemical assay for detecting damage to DNA and application of this technology to the study of cancer cells. This work should lead to the further development of chemical probes to monitor human tissue samples for lesions in DNA and which is predicted to help assess cancer development.